Androgen Receptor Action in Castration Resistant Prostate Cancer

Project Summary
A central hypothesis that drove the studies proposed in the currently funded P01 was that androgen receptor
(AR) remained an important driver in prostate cancer (PC) that becomes resistant to AR targeted therapies, and
that adaptations made by tumor cells as they progress create new dependencies and subsequent vulnerabilities
that can be exploited therapeutically. Hence, our overall goals were to elucidate clinically relevant mechanisms
and subsequent vulnerabilities that contribute to resistance to AR targeted therapy, and to identify therapeutic
approaches that exploit these resistance mechanisms. Work from us and others has supported the continued
central role for AR, and provide the rationale for the continued focus on AR in the studies proposed in this
renewal. Project 1 (Peter Nelson, PI) Identifying and Targeting Specific Determinants of the AR Cistrome
that Drive Prostate Cancer Cell Survival and Proliferation, focuses on identification of the critical functions
regulated by AR. It will test the hypotheses that AR directly transcriptionally regulates a signaling program that
promotes cell survival (anti-apoptosis) and cell division/proliferation, and that PCs resisting potent AR repression
may ‘bypass’ a requirement for AR signaling through genomic or epigenomic events that serve to maintain the
key survival/growth pathways normally regulated through AR activity. Project 2 (Steven Balk, PI) Identify
Mechanisms Driving Resistance to AR Antagonists in CRPC, remains focused on basic mechanisms of AR
transcriptional activity and mechanisms of resistance to AR antagonists such as enzalutamide (ENZ). The project
will tets the hypothesis that ENZ-resistant tumors are drive by ARv7, and that ARv7 activity is dependent on
increased chromatin accessibility mediated by FOXA1 and NFI proteins. Project 3 (Myles Brown, PI)
Functional Interplay Between PARP, AR and DNA Damage, builds upon efforts in the Brown lab to identify
critical modulators of AR activity in CRPC that may be therapeutic targets. PARP1 and PARP2 have been
implicated in various aspects of AR regulated gene expression, but the impact of PARP inhibition on the AR
cistrome and AR regulated gene expression has not been fully elucidated. Whether DNA damage resulting from
the loss of BRCA1 or BRCA2 alters AR function or whether BRCA1 or BRCA2 play direct roles in AR function
also remain to be defined. This provides the rationale for the proposed studies to obtain a detailed understanding
of the functional interplay between AR, PARP, BRCA1 and 2, and DNA damage. Core B (Biospecimen Core,
led by Eva Corey) will provide the Projects with access to a unique collection of well-characterized CRPC PDX
models, and more recently cell lines, as well as clinical samples and pathology expertise. Core C (Functional
Epigenetics Core, led by Henry Long) will provide each Project with expertise and resources for a variety of
genomic studies and associated computational support. Administrative Core (Core A, led by Steven Balk),
will provide administrative and biostatistical support.

Public health relevance
Project Narrative The overall goals of this P01 are to elucidate clinically relevant mechanisms and subsequent vulnerabilities that contribute to resistance to AR targeted therapy in prostate cancer (PC), and to identify therapeutic approaches that exploit these resistance mechanisms. The projects are 1) Identifying and Targeting Specific Determinants of the AR Cistrome that Drive Prostate Cancer Cell Survival and Proliferation, 2) Identify Mechanisms Driving Resistance to AR Antagonists in CRPC, and 3) Functional Interplay Between PARP, AR and DNA Damage.